Natural Language Processing and Machine Learning for Cancer Surveillance

The purpose of this call order is to provide support in the area of quality control and improvement of cancer data, specifically for Clinical Document Annotation and Processing Pipeline (CDAP), LabKey Software, and the development of annotation schema.